AFRO-AMERICAN ADOLESCENT GIRLS GROWTH AND DEVELOPMENT

The purpose of the study is to assess longitudinally among Afro-American girls the pattern and determinants of body weight, body composition, and aerobic fitness, and physical activity. This study is still in progress.